Myelin Disorders Biorepository Project (MDBP) at the Biospecimen Exchange for Neurological Disorders (BioSEND)

Summary of the Funded Grant or Project
The parent RDCRN program is the Global Leukodystrophy Initiative Clinical Trial Network (GLIA-CTN). This
program is in its first cycle (entering Y5) and is a collaboration of 8 US leukodystrophy centers. The primary aims
focus on harmonization and curation of leukodystrophy natural history data using standard functional and patient
reported outcome measures as well as electronic health records. The parent program supports the collection of
clinical data related but does not include the proposed biobanking approaches. This application is expected to
create the necessary infrastructure to include BioSEND prospectively in future GLIA-CTN activities.

Public health relevance
Narrative Emerging therapies in the leukodystrophies make it imperative to establish a reliable and disseminated resource for biosamples in this group of disorders. The Global Leukodystrophy Initiative (GLIA) proposes to collaborate with BioSEND to create a leukodystrophy specific biobank, the Myelin Disorders Bioregistry Project (MDBP@BioSEND). In this proposal, we will create the necessary infrastructure and demonstrate banking of initial samples from the GLIA RDCRN funded consortium.